INSULIN ACTION IN POLYCYSTIC OVARY SYNDROME

The purpose of this study is to better understand the relationship between reproductive function and diabetes. These studies will address how a slight excess of male hormones may decrease the body's sensitivity to the insulin.